Precise Wearable System for Accurate Continuous Gait Monitoring to Indicate Health Decline in Black Adults with Alzheimer's Disease and Related Dementias

Project Abstract
Roughly 6.9 million Americans over age 65 have Alzheimer’s disease and related dementias (ADRD). Black
Americans have ADRD at twice the rate of White Americans. Many Black adults are underdiagnosed or
diagnosed later in disease progression, which limits their treatment and support options. As well documented
disparities in healthcare and clinical access show, Black adults also have less in-home caregiving, resulting in
less monitoring of individuals’ health status, greater caregiver burnout, higher costs, and worse health
outcomes. Current methodologies for treatment of Alzheimer’s disease (AD) indicate the critical importance of
ongoing monitoring of functional status and disease progression to inform care and intervention decisions.
Therefore, capabilities for continuous assessment in the home with remote clinician access to these insights
are being pursued to help clinicians responsively target appropriate approaches to care for more patients. Gait
measures such as stride and speed are exemplary in predicting ADRD risk, health decline, and mortality.
However, current methods to measure gait require a clinic visit and dedicated laboratory hardware,
exacerbating healthcare disparities. Recent gait measurement and analysis systems show promise, but are not
designed for easy, long-term, and home-based telehealth, and would neither be accepted by patients with Mild
Cognitive Impairment (MCI) or ADRD, nor alleviate access disparities. There exists an unmet need to provide a
precise monitoring sensor solution optimized to measure gait patterns throughout the day that would assist
medical professionals and caregivers with an early indication of health decline in older Black adults. ASTER
Labs, Inc. proposes to design and construct a novel, unobtrusive device to continuously measure and analyze
the precise relative ranges between the feet, gauging gait during ambulation. The data will be shared with
clinicians to monitor patients for subtle or sudden changes indicating increased risk of AD onset, declining
health, or mortality. This practical, real-time, low-cost solution will easily operate within the familiarity of
patients’ homes to enhance the accuracy and availability of patient health metrics to caregivers, and improve
care and treatment planning. The system will be informative in course of care decisions between patients,
caregivers, and clinicians. The wearable device is discrete and comfortably worn as an insole in the patient’s
shoe. The system design uses an innovative set of radio frequency and magnetic field sensors integrated with
patented relative foot positioning algorithms that will provide continuous and precise results compared to
current capabilities. This novel, technically-advanced gait evaluation solution will provide Black persons with
dementia (PWD) and their care providers with regular on-demand access to accurate and comprehensive
information that can enable choices on interventions and improve quality of life.

Public health relevance
Project Narrative Accurate health status indicators are key factors in optimizing care regimes and treatment plans for the rapidly growing elderly population in the U.S., including those with Alzheimer’s disease and mild cognitive impairment, but healthcare disparities faced by Black Americans and other minority groups make obtaining these indicators a challenge. Gait has been found to be a key indicator, when combined with age and sex, of health status and decline in older adults, as it requires energy, movement control, and support. The proposed research seeks to enhance clinician and physician capabilities and address disparate access to ongoing gait assessment, by developing a highly precise continuous gait evaluation device to provide long-term and short-term in-home and in-clinic analysis of gait speed during bouts of activity and walking to assess the functional status of older adults with dementia.